HEAD START IMPACTS BEFORE AND AFTER THE TRANSITION TO KINDERGARTEN: THE MODERATING ROLE OF KINDERGARTEN CLASSROOM AND SCHOOL CONTEXTS IN EASTERN NORTH CAROLINA

The proposed dissertation study will examine comparable groups of children who either attended Head Start during their prekindergarten (pre-K) year or participated in some alternative type of child care arrangement. The impacts of Head Start participation on children’s social-emotional and academic competencies will be examined in the spring of children’s pre-K and kindergarten years.